Sialic acid mediated phagocytosis of oral streptococci.

Project Summary/Abstract
Viridans streptococci commonly found in the oral cavity as commensal bacteria can turn into opportunistic
pathogens if they gain access to the bloodstream where they can cause systemic disease. Neutrophils at the
gingival margin form a first line of defense by recognizing and destroying invading bacteria before they enter the
bloodstream. The mechanisms facilitating recognition of streptococci by neutrophils that result in phagocytosis
and killing of the streptococci are not completely understood. Many streptococcal strains express serine-rich
repeat protein adhesins (SRRPs) which facilitate host colonization by recognizing and binding to sialic acids, the
most common terminal glycans on glycoproteins in saliva and oral epithelial cells. Neutrophils also express
sialylated proteins, but sialic acid-dependent interactions between oral streptococci and neutrophils have not yet
been studied in sufficient detail. Recent work by our lab has identified strains of streptococci, obtained from the
human oral cavity, which exhibit differential binding to the two most common forms of mammalian sialic acids,
N-acetylneuraminic acid (Neu5Ac) and N-glycolylneuraminic acid (Neu5Gc), the latter of which humans are
unable to synthesize. The unexpected finding of streptococci in the human oral cavity which preferentially bind
to Neu5Gc led us to question whether this preference prevents these bacteria from being recognized and killed
by neutrophils. The question of whether human neutrophils, lacking Neu5Gc, are able to efficiently eliminate
Neu5Gc-binding streptococci will be addressed by this proposal. Our central hypothesis is that streptococcal
preference for specific sialic acid-containing epitopes results in different responses of neutrophils
encountering these streptococci. We will test this hypothesis by incubating streptococcal strains which exhibit
differential binding to Neu5Ac and Neu5Gc with neutrophils displaying either Neu5Ac, Neu5Gc, or which are
devoid of sialic acids. In Aim 1, neutrophil activation and phagocytosis of streptococci based on sialic acid
subtype preference is examined. Aim 2 will identify specific sialoglycoproteins on the surface of neutrophils
which are bound by either Neu5Ac- or Neu5Gc-specific streptococci or their purified adhesin proteins. We will
also test how these interactions with cell surface sialoglycoproteins contribute to neutrophil activation and
phagocytosis of the streptococci. This project advances the trainee’s knowledge and skills in glycobiology and
immunology acquired during his PhD dissertation research. The project will also permit the trainee to gain new
knowledge and skills in microbiology and innate host defense as it pertains to the oral cavity. The applicant’s
advisory committee members are committed to helping him develop the professional and academic skills
necessary to achieve the long-term goal of establishing an independent research laboratory. The project is
designed to provide preliminary data not only for a subsequent K99/R00 grant proposal, but also has the potential
to lead to a long-term research program unravelling glycan-mediated interactions between microbes and the
host as a novel aspect of innate host defense in the oral cavity.

Public health relevance
Project Narrative The human oral cavity harbors a dynamic array of commensal bacterial species, such as streptococci, which are normally harmless unless they enter the bloodstream, where they can cause systemic infections. Neutrophils at the gingival margin act as a first line of host defense to prevent infection by such potentially pathogenic bacteria. This project investigates an incompletely understood glycan-mediated mechanism of host defense, namely how neutrophil sialic acids, sugar molecules decorating cell surface proteins, mediate recognition and eventual destruction of sialic-acid-binding oral streptococci.